Diagnosis and Risk factors of hippocampal sclerosis of aging and limbic predominant age related TDP-43 encephalopathy; common Alzheimer’s mimics

Hippocampal sclerosis of aging (HS-A) and Limbic predominant age related TDP-43 encephalopathy
neuropathologic change (LATE-NC) are important degenerative pathologies that are closely related but distinct.
Around 20% of older age dementia is attributable to these two conditions. HS-A is diagnosed when there is
disproportionate atrophy in a brain structure called hippocampus and LATE-NC is characterized by abnormality
of an essential protein, TDP-43. Clinically, both pathologic changes mimic Alzheimer’s disease pathology and
present with memory problems. Despite their importance, none of the pathologies can be diagnosed during life
and can only be found by examining the brain after patients die. Moreover, both HS-A and LATE-NC frequently
co-occur with Alzheimer’s disease pathology. This makes their diagnosis even more challenging. This is
especially important in an era that specific treatments for these protein abnormalities are being developed.
Therefore, there is significant unmet need for discovering ways to diagnose them during life.
In the current cycle of the grant, we showed that our quantitative method is more informative than standard
pathologic measures in identifying relationships between HS-A and clinical impairment and presence of other
pathologies. We also found that clinical features of HS-A and LATE-NC are remarkably similar to Alzheimer’s
disease. We found that MRI detects atrophy of hippocampus in HS-A, and this is an early finding making MRI a
suitable tool for HS-A diagnosis. We have also found indications that autoimmunity plays a role in HS-A.
The objective of this proposal is to advance our HS-A discoveries and to start new investigations on pathological
assessment and diagnosis of LATE-NC in an ethnically diverse group of participants. Inclusion of ethnically
diverse participants will allow for studying the prevalence and impact of these important pathologies in a
representative sample of our population. The study will use the resources of four ongoing studies of older
individuals across two Alzheimer’s disease research centers at University of California (UC), Irvine and UC Davis,
The 90+ Study, and LifeAfter90 Study.
In aim 1, we will replicate our HS-A results in a new and ethnically diverse group of participants that will
validate our methods. We will also test the hypothesis that quantitative assessment of LATE-NC will identify
novel associations with cognitive impairment and other brain pathologies. In aim 2, we will test the hypothesis
that brain MRI and glucose PET scan, can identify features that are specific to HS-A and LATE-NC. In aim 3,
we hypothesize that blood markers of autoimmunity and inflammation are related to HS-A and LATE-NC
respectively and measuring TDP-43 and progranulin in blood, can serve as markers of LATE-NC.
Successful completion of this proposal, we lead to major advancement in the diagnosis of two important dementia
related pathologies that cannot be diagnosed during life. This will not only enable realistic assessment of the
effectiveness of Alzheimer’s therapies but will also pave the way for clinical trials of HS-A and LATE-NC.

Public health relevance
The proposed research is relevant to public health because its goal is to enable the diagnosis of two important brain pathologies that account for more than 20% of dementia cases in those who are 85 years and older. This age group is the fastest growing segment of the population and has the highest rates of dementia. Around half of those suffering from dementia by mid-century will belong to this group highlighting the importance of studies dedicated to the causes of dementia in this older age.